Non-Invasive Home Neurostimulation for Mild to Moderate Alzheimer's Disease: Double-Blind, Sham Controlled Randomized Clinical Trial

Abstract
The growing prevalence of Alzheimer’s Disease coupled with a dearth of effective treatment options
necessitates the development of novel treatment approaches for Alzheimer’s Disease, particularly
those that pose minimal risk of adverse effects in a medically fragile population. Minimal risk, non-
invasive neuromodulatory therapies, such as transcranial direct current stimulation (tDCS), may relieve
symptoms and enhance function in older adults with diverse conditions. We developed an at home
tDCS and demonstrated the feasibility of this approach, and in a pilot study conducted in patients with
early Alzheimer’s disease, at home tDCS improved cognitive performance as well as stability in brain
metabolism.
We now propose to build and expand on the pilot study to test the clinical efficacy of home based tDCS
using a rigorous double blind randomized clinical trial design in 100 patients with mild to moderate
Alzheimer’s disease who will be randomized to receive either tDCS five days per week for six months
at home or to sham treatment at the same frequency. All participants will receive cognitive assessments
at baseline, post-intervention, and at one month and three months after intervention to explore and
document durability of effects. Our primary outcome is change in cognitive performance (assessed by
the Alzheimer's Disease Assessment Scale - Cognitive subscale test). Secondary outcomes include
measures of mood, quality of life, and patient satisfaction with both the device and procedure.
Neuroimaging markers of potential neuroplasticity will also be evaluated at baseline, post-intervention,
and at three months post-intervention.
We predict that the active tDCS will result in better cognitive performance, and higher quality of life, as
compared to sham, and will be a satisfactory treatment approach for patients and their families. We
also hypothesize that the clinical response produced by active tDCS will be associated with improved
functional and structural connectivity and use of the Dorsolateral Prefrontal Cortex and associated
networks (e.g. executive control/salience networks).
The proposed study is highly responsive to PAR-19-298, which solicits applications to establish initial
efficacy of neurostimulation/neuromodulation in the treatment of Alzheimer’s disease and related
dementia. Our proposed clinical trial will provide high-quality evidence about the efficacy of at-home
tDCS in the treatment of Alzheimer’s Disease. If efficacy is demonstrated, this non-invasive, non-
pharmacologic intervention may become an important part of dementia care.

Public health relevance
NARRATIVE The prevalence of Alzheimer’s Disease is rising, but existing medications provide only modest control of cognitive decline and associated symptoms, and novel therapies are urgently needed. This randomized controlled trial will determine if an innovative low-risk neurostimulation at home can improve cognitive performance and symptoms in patients with mild to moderate Alzheimer’s Disease. If effective, this novel intervention can substantially enhance Alzheimer’s Disease symptom management at home, improve quality of life of Alzheimer’s Disease patients and their families, and reduce burden associated with this debilitating illness.